Path B New Jersey Department of Agriculture's Continued Implementation of the Produce Safety Rule

Project Summary/Abstract
Under the PAR-21-174 Funding Opportunity, the NJDA will be pursuing Path B. The NJDA will continue
its work on implementation of the FSMA Produce Safety Rule by building on progress achieved during
the previous funding opportunity. The goals of the funding opportunity and the NJDA in general remain
the same – promoting a proactive food safety culture, educating the grower population, and enforcing
the Produce Safety Rule in an effort to keep people safe.
Throughout the funding opportunity, the NJDA will focus it’s efforts verifying our covered farm
inventory – ensuring that all 3 tiers of farms are completely verified by the end of the grant. To do this,
we will use existing departmental lists – as in the past – as well as local tax records to find farms that
may not be on our radar. In addition, education of all covered farms is a priority. We will be working
with our sub awardee Rutgers University to educate new farms discovered through our inventory
verification efforts and offer continuing education and resources to farms who need it through our new
produce safety website. Lastly, we will continue the progress made on the regulatory side – all covered
farms will undergo an initial Produce Safety Rule inspection by the end of the grant. To help achieve this,
we have switched to an online database, USA Plants, to ensure secure documentation of inspections and
farm information.
The NJDA believes these are attainable goals with the help of the funding opportunity. During the next 5
years, the NJDA can further grow it’s produce safety program and form a multi-state produce safety
network with the overall mission of a proactive food safety program that keeps everyone safe.

Public health relevance
The New Jersey Department of Agriculture will continue to establish a proactive, multi state produce safety network through education and regulation with a focus on inventory verification, education to all covered growers, and regulatory visits for all covered farms. We will work with our sub award to offer resources to growers on produce safety related topics and begin using an online system for tracking and storing inspection information. We believe this combination of efforts will lead to successful implementation of the Produce Safety Rule.